The role of PLIN5 deficiency in podocyte lipotoxicity and progression of Alport Syndrome

PROJECT SUMMARY/ABSTRACT
Alport Syndrome (AS) is a hereditary disease caused by mutations in collagen type IV, a main component of the
glomerular basement membrane (GBM). Podocytes are key components of the glomerular filtration barrier, and
their interaction with the GBM is crucial to maintain the permeability of this barrier. We have demonstrated that
pathogenic renal lipid accumulation occurs in an experimental model of AS and that podocyte lipotoxicity is the
key determinant of podocyte injury in other glomerular disease. My preliminary data show that the intracellular
triglyceride (TG) content is increased in glomeruli of Col4a3 KO mice, a mouse model for AS as well as in
immortalized podocytes which I established from these mice (AS podocytes). Yet, the detailed mechanism by
which lipid accumulation contributes to podocyte lipotoxicity in AS remains to be elucidated.
The proposed research will explore a novel mechanism linking PLIN5 deficiency to podocyte lipotoxicity.
PLIN5 is a protein controls lipolysis and regulates free fatty acid (FFA) flux from lipid droplets (LDs) to
mitochondrial by establishing physical contact between these organelles. From my preliminary data, I generated
the hypothesis that PLIN5 deficiency in AS causes excessive TG lipolysis and loss of LD-mitochondrial
contacts resulting in FFA accumulation and mitochondrial dysfunction.
I propose the following specific aims using innovative cell biological, imaging analysis, and mouse model
approaches: (SA1) investigate the role of podocyte PLIN5 in recruiting LDs to mitochondria. (SA2) Define the
contribution of PLIN5 deficiency to mitochondrial dysfunction and renal failure in AS.
I have created a comprehensive career development plan supported by my mentor and co-mentors to
(1) ensure my progress and success in carrying out this research proposal and (2) to facilitate my
transition to an independent research career focused on lipid metabolism in association with
mitochondrial function in Alport Syndrome. This plan includes (1) regular meetings with my mentor, co-
mentors, and advisory committee, (national and global academic readers in medicine and science) to provide
research and career guidance, (2) research and career development seminars, learning new methodologies of
microscopy, mitochondrial function, and lipidomics, and (3) activities for career growth including mentoring,
publication, presentation, and application for independent research funding. My mentor and I have also agreed
upon a transition plan to distinguish myself from my mentor’s laboratory. My training will be carried out in an
unparalleled academic environment at University of Miami, Miller School of Medicine, which provides dedicated
career development programs and all necessary research support and supplies through his mentor, co-mentors,
and institutional core services. Collectively, this research and career development proposal is a product of
my ambition and capacity to transition to an independent research career.

Public health relevance
PROJECT NARRATIVE Alport Syndrome (AS) is an inherited disease that affects the kidney, the ear, and the eye; patients with AS often require dialysis early in life. We show that deficiency of a protein named perilipin 5 (PLIN5) affects the respiratory function of podocytes, a key cellular constituent of the kidney filtration barrier. Findings from this proposal may allow for the identification of a new function of a drug called Ezetimibe which was developed for the cure of high cholesterol and may be helpful in preventing kidney disease in AS by regulating PLIN5 expression.